TARGET INTERACTIONS OF EDINGER WESTPHAL NEURONS

The Edinger Westphal (EW) - ciliary ganglion (CG) pathway controls accommodation, iris constriction, and possibly blood flow in the choroid and as such, is important for normal eye function and clinical diagnosis. The longterm objective of this project is to identify the factors which influence the formation and maintenance of synaptic contacts between EW and CG neurons. Experiments will use a well established culture system combined with intracellular electrophysiology and immunohistochemistry to determine what elements contribute to the development of EW terminal morphology as well as to the formation of functional synapses with CG neurons. Previous work has found that calyx-like contacts, which mimic the unusual cup-shaped morphology of EW calyciform terminals in vivo, are found preferentially on CG neurons when EW neurons are cultured together with both dorsal root ganglion and CG neurons. The specificity of this interaction is an unusual departure from the promiscuity often displayed by neurons in vitro and may yield new insights into the process of synaptic terminal morphogenesis. For this reason, this project focusses on the formation of these calyx-like contacts as well as on the formation of functional synapses between EW and CG neurons in vitro. There are five specific aims which address the following five sets of questions: (1) What morphological and physiological characteristics of EW calyciform synaptic terminals are expressed in culture? (2) What distinctions between subpopulations of CG neurons are retained in culture? Are calyx-like contacts limited to a specific subpopulation of CG neurons as they are in the ganglion? (3) To what extent is the identity of the presynaptic neuron involved in synaptic specificity? Can EW neurons compete with inappropriate inputs and displace them in the formation of synapses and calyx-like contacts on CG neurons? Can CG neurons elicit calyx-like morphology from any presynaptic neuron? (4) Do EW and CG neurons acquire the ability to form or elicit calyx-like morphology at a particular developmental stage? (5) Are electrical activity and/or neurotransmitter mediated interactions required for the formation of calyx-like contacts between EW and CG neurons in vitro?